Summer research experiences for medical students supervised by faculty mentors

Project Summary / Abstract
The Memorial Sloan Kettering Cancer Center (MSK) Summer Research Fellowship Program is a cancer
education program that enables 30 first- and second-year U.S. medical students to participate in laboratory and
clinical research under the mentorship of MSK’s clinical faculty. Launched in 1977, this program has enabled
approximately 1,610 medical students to contribute to the research enterprise of a premier academic medical
center. Program participants can work with mentors and in labs centrally involved in both basic and clinical
research; attend MSK’s abundant didactic opportunities; learn how to blend lessons from science and clinical
practice; and present their work to a range of audiences.
The MSK Summer Research Fellowship Program helps address two significant challenges in the field of
oncology.
• The need for more oncologists, especially physician-scientists: In a 2014 report, the American
Society of Clinical Oncology (ASCO) projected a shortage of oncologists over the next decade due to
several factors, including the aging population and an aging oncology workforce. Also, in 2014, the NIH
issued a report that anticipates that the rising generation of physician-scientists will be insufficient to
replace those nearing retirement age. The rapidly advancing field of cancer care requires an oncology
workforce of appropriately trained and engaged physician-scientists that can maintain the pace of
translation research developments. This program aims to ameliorate this shortage by engaging students’
interest in oncology research careers.
• The need for more physicians from underrepresented minority populations: The report from ASCO
described a need for greater racial and ethnic diversity in the physician workforce. This program has
been able to grow in both size and diversity through the support of MSK’s Office of Diversity Programs.
In the most recent grant cycle, approximately half of our participants were from underrepresented minority
groups.

Public health relevance
Project Narrative The Memorial Sloan Kettering Cancer Center Summer Research Fellowship Program is a ten-week research- training program developed for medical students hailing from diverse backgrounds. It is intended to encourage student interest in careers in biomedical research and oncology. The program encompasses laboratory-based research, didactic learning, and clinical exposure and program’s participants include a large proportion of students from minority groups that are underrepresented in the oncology workforce.